Physiological determinants of suprathreshold deficits in sensorineural hearing loss

Project Summary/Abstract
Current assessments and treatments for hearing loss focus on restoring hearing sensitivity and speech
audibility through amplification. Yet, hearing-aid users struggle to understand audible speech, especially
in environments with background noise. Little is known about the precise physiological mechanisms that
contribute to the challenge of being able to “hear, but not understand.” Conventionally, such
suprathreshold deficits are attributed to reduced cochlear frequency selectivity (i.e., broadened filter tips)
or cognitive factors like attention and memory. In contrast, emerging evidence from animal models of
sensorineural hearing loss (SNHL) and preliminary data from human patients suggest that two
underrecognized mechanisms may be prominent contributors. First, hair-cell injury dramatically distorts
peripheral tonotopicity such that low-frequency sounds dominate the temporal response of the high-
frequency basal half of the cochlea, excluding high-frequency information. Second, SNHL unleashes
compensatory alterations in the balance of excitation and inhibition in downstream neural circuits,
disrupting our ability to analyze the encoded acoustic scene and discern target sounds from background
noise. The proposed research program will characterize these suprathreshold sequelae of SNHL and
quantify their contribution to individual listening outcomes. Aim 1 will characterize the effects of distorted
tonotopy on neural coding and perception of speech-in-noise by measuring psychophysical tuning
curves, EEG, and psychoacoustic responses to speech in various noise conditions in participants with
SNHL and age-matched controls. Aim 2 will characterize the effects of central plasticity through EEG-
based central-gain metrics and along with EEG and psychoacoustic indices of scene analysis based on
temporal-coherence statistics, which are prominent cues for target-masker contrast in naturalistic sounds,
and whose analysis depends on intact balance of excitation and inhibition. We will isolate central gain
effects without confounding cochlear tuning changes by comparing (2.1) middle-aged participants with
cochlear deafferentation to young controls, (2.2) young individuals pre and post temporary central-gain
induction through ear-plug use. Aim 3 will develop personalized SNHL profiles, using metrics of distorted
tonotopy and central gain, to predict speech-in-noise performance and listening effort with hearing aids
in a diverse cohort of SNHL patients. This project harnesses the team’s multidisciplinary expertise in
clinical audiology, EEG, psychoacoustics, and pupillometry, and will also leverage a large institutional
research registry with over 37,000 potential adult participants with varying ages and degrees of hearing
loss. Taken together, the proposed research program will broadly advance the field by elucidating the
complex effects of cochlear injury and central plasticity on suprathreshold outcomes in SNHL.

Public health relevance
Project Narrative Current audiological assessments and treatments for sensorineural hearing loss focus on restoring lost hearing sensitivity and making speech sounds more audible through hearing aids. However, many hearing- aid users still struggle to understand audible speech, especially in environments with background noise. Drawing from emerging animal studies, the proposed research program will use a multidisciplinary approach in human participants to comprehensively characterize two key mechanisms could contribute to the challenge of “hearing but not understanding”: loss of inner-ear tonotopy, and brain changes that invariably follow hearing loss.